Peroxisome biogenesis disorders (PBDs)

In collaboration with J. Hacia (USC), N. Braverman (McGill University), and pending postdoctoral support by the Global Foundation for Peroxisome Disorders (GFPD) and the Wynn Foundation the ADST laboratory of NCATS is optimizing a 1536-well plate format high content automated microscopy-based imaging assay for the identification of phenotype-perturbing substances from NCATS chemical libraries. Initial work on this project has included quantitative HTS with libraries of bioactive chemical probes and approved drugs. Compounds identified in these initial screens are currently being tested for activity in a series of biological validation assays in the Hacia lab at USC to substantiate that the phenotypic response observed in the HTS assay is reflective of an effect on persoxisomal biogenesis. In addition, transgenic mouse models with various PBD mutations are being developed in the Braverman lab at McGill University as models for both peripheral and CNS phenotypes of the disease.